RFA-GH-22-001, Monitoring morbidity, evaluation of new diagnostic tools; interventions to reduce or interrupt transmission, and improving surveillance for intestinal schistosomiasis.

Project Summary/Abstract
Schistosomiasis (SCH) presents with a range of morbidities, some of these are common to infection
with either species (such as anemia and impaired growth) and some are species-specific (e.g.,
hepatomegaly in Schistosoma mansoni infections and hydronephrosis in S. haematobium infections).
Although recent years have witnessed a scale-up of mass drug administration (MDA) for SCH control
worldwide, no single direct morbidity marker has been adopted to monitor the clinical impact of MDA.
Proper disease surveillance encompassing robust monitoring and evaluation (M&E) activities remains
a key ingredient in ensuring the success of disease control programs. At the front and center of any
successful surveillance efforts is the need for new and improved diagnostics. Unfortunately, the
diagnostic tools for SCH and soil-transmitted helminthiasis (STH) can have low sensitivity in persons
with light infections and are currently too expensive to use for routine annual M&E. In addition to
effective diagnostic tools, pharmacovigilance for new treatments or formulations and other alternative
control interventions including snail control also remain central in efforts to interrupt transmission. In
order to arrive at the expected objective of monitoring morbidity, evaluation of new diagnostic
tools and interventions to reduce or interrupt transmission, and improving surveillance for S.
mansoni and STH in western Kenya, 4 sets of interconnected studies are proposed. A cross-sectional
survey design will be utilized to identify infection levels of S. mansoni (Sm) below which there is little,
or no, detectable schistosomiasis-associated liver morbidity and markers for M&E of SCH control in
Siaya (Sm-endemic) and Vihiga (Sm-non-endemic) counties, western Kenya (Objective 1). Several
outcomes will be assessed annually (stool microscopy, malaria, anaemia) and at baseline, mid-term
and end-term (abdominal ultrasound, intestinal inflammation) among school-age children (SAC, 8-14
years), adolescents (≥14 to <18 years) and adults (≥y18 to 60 years). As part of surveillance efforts
and M&E, Objective 2 will determine the impact of the WASH strategy as one of the intervention
packages in the Kenya MoH NTD program’s Breaking Transmission Strategy (BTS) in one sub-
County in Vihiga (WASH area) and Homabay(non-WASH area) counties (Objective 2, Aim 1). WASH
levels associated with increased impact of MDA on SCH and STH will be determined based on
carefully designed WASH questionnaires administered cross-sectionally to 300 SAC (8-14 years) and
100 household heads (18-60 years) within 2 Wards in each sub-County at baseline, mid-term and
end of study. Stool and urine samples will be collected from the same SAC with WASH data at each
timepoint and will be used to assess infection status for S. mansoni and STH (Kato-Katz for stool;
POC-CCA for urine). A WASH assessment tool that can identify community targets to help reduce
prevalence will be validated. As part of additional surveillance activities, the presence, species type
and infectivity of intermediate snail vectors for schistosomiasis will be assessed in 5 wards with
highest S. mansoni prevalence in Kakamega, Bungoma, Vihiga and Trans Nzoia counties of western
Kenya so as to inform snail control activities for the National NTD Control program (Objective 2, Aim
2). For Objective 3, Aim 1, a sub-set of samples collected through Objectives 1 and 2 above will be
used as materials for evaluation and validation of the urine Up-converting particle lateral flow
circulating anodic antigen (UCP-LF-CAA) for diagnosis of schistosomiasis by comparing it with the
standard Kato-Katz technique. For Objective 3, Aim 2, a sub-set of samples collected through
Objectives 1 and 2 above will contribute to a sample biobank/repository for the evaluation and
validation of currently developed and future diagnostic technologies for SCH & STH. Contingent on
roll-out of L-praziquantel orodispersible tablet (arpraziquantel) treatment in young children (post-
registration approval expected in 2025/2026) and availability of funding, the focus for Objective 4 will
be to evaluate efficacy, impact and side effects of the new arpraziquantel for treatment of
schistosomiasis in young children in select sub-Counties of western Kenya. Outcomes from the
proposed work include data on alternative approaches for assessment of morbidity for S. mansoni,
evaluation of the Kenya BTS for SCH and STH, data to guide snail control efforts and contribution to
improved diagnostic tools and sample biobanking. Collectively, these outcomes will not only advance
our knowledge, but also contribute to fulfilling CDC’s purpose to support implementation of research
studies that will provide critical information on ways to monitor, control, and potentially eliminate
parasitic diseases including SCH & STH, with a view to yield high impact public health findings and
to improve strategies that will decrease the overall burden of parasitic diseases and increase the
health and wellbeing of affected populations.

Public health relevance
Project Narrative Schistosomiasis (SCH) and soil-transmitted helminthiasis (STH) are major global public health problems. SCH presents with a range of morbidities, and although recent years have witnessed a scale-up of MDA for SCH control worldwide, no single direct morbidity marker has been adopted to monitor the clinical impact of these interventions. It is widely appreciated that the critical infection levels associated with SCH morbidity are poorly understood and evidence-based targets for control are lacking. On the other hand, while MDA has contributed to reduction of prevalence and intensity of SCH & STH over the decades, it is acknowledged that MDA alone is unlikely to interrupt transmission of these diseases. Other control measures such as provision of water, sanitation, and hygiene (WASH) are needed, but the threshold of WASH levels/indicators that are associated with the greatest impact of MDA need to be ascertained. Proper disease surveillance encompassing robust monitoring and evaluation (M&E) activities for all control measures including WASH and vector control remains a key ingredient in ensuring the success of control programs and activities against these diseases. Planning for control interventions including MDA to control S. mansoni requires accurate testing and mapping to determine local parasite prevalence. Although Kato-Katz is recommended by the WHO for detection of intestinal schistosomiasis, there is increasing appreciation that the sensitivity of Kato-Katz stool analysis will continue decline, especially as more MDA programs are expanded and progressively lower egg densities are observed. New and improved diagnostics are therefore needed to ensure and to support successful disease surveillance, M&E of control programs. At the same time, pharmacovigilance for new treatments or formulations and other alternative control interventions including snail control also remain central in efforts to interrupt transmission. The proposed 4 studies that are interconnected and targeting SCH & STH in western Kenya will evaluate and monitor morbidity, evaluate new diagnostic tools and interventions including WASH and snail monitoring to reduce or interrupt transmission, and evaluate safety, efficacy and impact of new treatments or new formulations of existing treatments for SCH as they become available.